MOLECULAR INTERACTIONS OF FACTOR XI

Recent published work on the biochemistry, molecular biology and physiology of FXI has refocused attention on the biological importance of this unique and interesting protein. Previous studies from our laboratory (currently supported by NIH HL46213 "Molecular Interactions of Factor XI"), for which we now seek continued support, as well as work from other laboratories have focused attention upon FXI and its interactions with other plasma proteins [i.e., thrombin, FXIa, FXIIa, prothrombin, HK, and FIX], with the platelet plasma membrane and with various inhibitory molecules [e.g., alpha-1-protease inhibitor (alpha1PI), and protease nexin II (PN2)] in the initiation and regulation of blood coagulation. Recent observations resulting in the recognition of the essential role of FXI in hemostasis concern the relationship of its domain structure to its biological function, the molecular genetics of FXI, its molecular and cellular interactions, the elucidation of newly discovered pathways for activation of FXI, and the expression and regulation of its enzymatic activity. The long term goals of the present proposal are to elucidate the molecular mechanisms involved in the interaction of FXI/FXIa with protein and cell surface ligands involved in its activation and with plasma protein and cell surface ligands involved in the expression and regulation of FXIa enzymatic activity. Specifically we propose: 1) To define the mechanism of homodimer formation mediated by the Apple 4 (A4) domain of FXI by carrying out a detailed physicochemical characterization of dimer formation using the rA4 domain. 2) To determine the morphology of the interface mediating dimer formation between the A4 domains of FXI. 3) To ascertain the structural determinants of dimer formation in full-length FXI using loss of function and gain of function chimeric rFXI/PK hybrids and FXI mutants using homology scanning and alanine scanning mutagenesis. 4) To determine the functional significance of dimer formation using conformationally constrained synthetic peptides and rFXI mutants designed to produce a monomeric FXI molecule. 5) To determine the most physiologically relevant surface(s), enzyme(s), cofactor(s), and FXI subdomains required for FXI activation. These proposed studies will enable us to utilize combined immunochemical, biochemical and molecular biological techniques to provide definitive information about the structure of FXI/FXIa domains essential for these important intermolecular interactions and to define the structure/function relationships involved in the initiation and regulation of intrinsic coagulation.